Chloride fluxes in organellar membranes

This project is using a combination of methods to analyze the ion transport properties of lysosomal membranes. Lysosomes are intracellular organelles that serve in most cells as digestive organelles although in some tissues they are used for other functions. Disorders of lysosome function lead to a variety of diseases including neurological dysfunction (lysosomal storage diseases) and osteopetrosis (overcalcification of bone). Lysosomes utilize an ATP-driven proton pump to maintain an acidic luminal pH and facilitate their digestive function. Such a pump can only be effective if accompanied by additional ion transport to dissipate the transmembrane voltage built up by the ATPase, a counterion pathway. We recently used isolated lysosomes to identify and characterize a Chloride permeability in the lysosomal membrane which has the features required of such a counterion pathway and demonstrated that the chloride is transported by ClC-7, a Cl-/H+ antiporter specifically targeted to the lysosomal membrane. Over the past fewyears we have been working to develop methods to accurately meaure the pH in lysosomes in living cells in order to determine the influence of ClC-7 and other transporters on the lysosomal pH. These methods use dual-wavelength ratiometric fluorophores linked to dextran to specifically target lysosomes. pH is measured by processing images of the cells taken at the two wavelengths. We have been collaborating with investigators in CIT to develop algorithms to accurately reconstruct 3-Dimensional maps of all dextran-labeled lysosomes in a cell; these methods will be useful for understanding the pH distribution among lysosomes. We have worked out methods to accurately calibrate the system to correlate image measurements with actual pH values. We have now analyzed the effects of ClC-7 gene knockdown on cells where siRNA controls do not affect lysosome pH and are completeing controls required to finalize this work. We have also nearly completed an analysis of the ion requirements of acidification in isolated lysosomes which will be written up in the next year. We have also constructed ClC-7 knockout mice to further explore the role of ClC-7 in lysosomal acidification. We have characterized the acidification process in mouse liver lysosomes and found that they generally behave similarly to those from rat liver. We are currently characterizing the lysosomes from ClC-7 knockout mice. We are also beginning to explore the influences of other metabolic processes on the pH of lysosomes, since lysosomes have recently been shown to serve as important monitoring stations for cellular metabolic stress. In addition to our work on lysosomes, we have begun to explore the acidification process in other organelles. In particular, we have developed methods to isolate clathrin-coated vesicles from bovine brain. These vesicles are known to acidify using a v-type ATPase and have been suggested to use an anion as a counterion for acidification. This year we demonstrated that Cl- is is critical for v-ATPase induced acidficiation in our CCV prep and that monovalent cations have minimal effects. We are currently working to identify the specific vesicle population undergoing acidification in these preps and to identify the transporter mediating this counterion pathway.